Role of Phox2b in mouse respiratory chemoreceptor neurons

PROJECT SUMMARY
Congenital central hypoventilation syndrome (CCHS) is an autonomic and respiratory disorder caused by
mutations in the paired-like homeobox transcription factor gene, PHOX2B. CCHS patients have severe
episodes of hypoventilation, especially during sleep, that likely reflect reduced arousal and ventilatory
responses to high CO2. In CCHS, PHOX2B mutations commonly include polyalanine repeat mutations
(PARMs), with increasing severity associated with more extensive expansions, along with other loss-of-function
gene variants that yield particularly dire clinical presentations including various accompanying dysautonomia.
The neuropathology associated with CCHS-causing mutations in humans has not been delineated. In mice,
Phox2b is expressed in several brain-stem neurons that may be relevant for various clinical features of CCHS.
However, the respiratory chemosensory neurons of the retrotrapezoid nucleus (RTN) are thought to be
particularly important for the alveolar hypoventilation and loss CO2-dependent reflexes, the two cardinal signs
of CCHS, because they are intrinsically CO2-sensitive, contribute to breathing and waking reflexes activated by
hypoventilation, and they are uniquely eliminated in mouse genetic models of CCHS. The transcriptional role
of Phox2b in RTN neurons, and how it contributes to respiratory regulation by those neurons has not been
determined. This proposal examines gene regulatory functions of wild type and polyalanine mutants of Phox2b
in RTN neurons, and the relevance of Phox2b-regulated genes for RTN function in respiratory control.

Public health relevance
PROJECT NARRATIVE Phox2b is one of the four transcription factors that defines the development, differentiation, and migration of RTN neurons, a critical set of CO2/H+-sensing respiratory chemoreceptor neurons in mice, and its expression persists throughout the postnatal period. In human patients, mutations in PHOX2B are diagnostic of congenital central hypoventilation syndrome (CCHS), characterized most famously by disruptions in CO2-dependent breathing and arousal reflexes. The precise transcriptional role of Phox2b in RTN neurons, and how disruption/mutation of Phox2b expression leads to the clinical signs associated with CCHS have not been determined. In this application, we propose a viral-mediated approach to examine effects of Phox2b depletion and mutation selectively in RTN chemoreceptor neurons implicated in CCHS to determine effects on gene expression and on CO2-dependent breathing and arousal.